Porous silicon microparticle-based subunit vaccines for SARS-CoV-2

SUMMARY:
The Coronavirus disease 2019 virus (COVID-19) pandemic has made a devastating impact on global public
health and economy over the past three years. Despite the success in rapid progress of COVID-19 vaccine
development, increasing rates of variants of concern (VOCs) with enhanced viral transmission and disease
severity, and/or ability to escape vaccine-induced immunity have challenged the global vaccine efficiency
efforts. Continuous work toward optimizing existing vaccine platforms and development of more effective novel
vaccines is needed. Intranasal immunization can lead to the induction of antigen-specific immunity in both the
mucosal and systemic immune compartments, and thus is effective in control of SARS-CoV-2 infection and
disease. However, most SARS-CoV-2 vaccines granted for emergency use authorization or in clinical trials are
limited to parenteral delivery as soluble antigens do not breach the nasal epithelial barrier but are transported
by microfold cells. We recently reported that a modified porous silicon microparticle (mPSM) adjuvant to
SARS-CoV-2 receptor-binding domain (RBD) vaccine triggered potent and durable systemic humoral and type
1 helper T cell- mediated immune responses following parenteral vaccination. mPSM also facilitated mucosal
uptake of SARS-CoV-2 RBD antigens. Two doses of parenteral and intranasal combined vaccinations with
mPSM-RBD elicited more potent lung resident T and B cells and mucosal IgA responses than parenteral
vaccinations alone, which led to markedly diminished viral loads and inflammation in the lung following SARS-
CoV-2 Delta variant challenge. Our results suggest that mPSM is an effective adjuvant for SARS-CoV-2
subunit vaccine in both systemic and mucosal vaccinations. We also found that combinatorial mRNA-
S+Nucleocapsid (N) vaccination provided stronger protection against Delta and Omicron variants infection than
the clinically approved S-expressing mRNA vaccine alone. Thus, to further optimize the immunogenicity of
mPSM-adjuvanted subunit vaccine, we will modify the formulation of antigens. Here, we hypothesize that
parenteral and intranasal vaccination with mPSM-based subunit vaccine triggers durable systemic and
mucosal immune responses which provide cross protection against SARS-CoV-2 VOCs infection and
transmission. We will initially optimize the immunogenicity and test the safety of m-PSM subunit vaccines in
mice (Aim 1). Next, we will study the protective efficacy of parenteral and intranasal vaccination with m-PSM
subunit vaccine against SARS-CoV-2 VOCs infection in young and aged mice and identify the immune
correlates of host protection (Aim 2). Lastly, we will confirm the immunogenicity of m-PSM subunit vaccine in
hamsters and evaluate its efficacy on prevention of SARS-CoV-2 VOCs transmission and enhanced control of
infection (Aim 3). The result of this project will be an effective SARS-CoV-2 vaccine candidate that induces
balanced systemic and mucosal immunity, provides long-lived cross-reactive host protection against SARS-
CoV-2 VOCs, and prepares us for future coronavirus outbreaks.

Public health relevance
PROJECT NARRATIVE: The current Coronavirus disease 2019 virus (COVID-19) pandemic has made a serious impact on global public health and economy. The goal of this project is to develop COVID-19 subunit vaccine formulated by a modified porous silicon microparticle and delivered by parenteral and mucosal prime/boost vaccination. This vaccine approach is expected to generate both systemic and mucosal humoral and Th-1 directed cellular immune responses, which will provide long-lasting cross protection against SARS-CoV-2 variants of concern and prevention of future coronavirus outbreaks.